Mathematical modeling of Mycobacterium tuberculosis dissemination

Research Summary
Tuberculosis (TB), a disease caused by the bacteria Mycobacterium tuberculosis (Mtb), remains a major infec-
tious disease of humans in the world. After the initial local infection of one site in the lung Mtb somehow dissem-
inates in the lung and often spreads beyond the lung. In fact, extrapulmonary TB is a hallmark of the disease in
young children and immunocompromised adults that is difﬁcult to diagnose and treat. Our understanding of Mtb
dissemination, both within the lung and beyond, remains limited, however. In this proposal we assembled a team
of scientists with expertise in computational biology (Ganusov, Aitchison, Duffy, Langston) and TB pathogenesis
(Urdahl, Sherman, Behar) to provide quantitative understanding of mechanisms of Mtb dissemination the lung
and systemically. To this end, we will be using a number of highly innovative techniques such as i) a novel animal
model of TB: infection of mice with an ultra low dose (ULD, 1-3 colony forming units, CFU) of Mtb along with a set
of 50 barcoded Mtb strains, ii) an Mtb strain H37Rv-pBP10 with the replication clock plasmid, allowing to estimate
how quickly bacteria are eliminated in vivo, and iii) mRNA-based gene signatures predicting bacterial numbers in
murine lungs and TB disease progression risk in humans. With three complementary speciﬁc aims we will pro-
vide detailed, quantitative understanding of fundamental processes of how Mtb disseminates from the deposition
in lung alveoli to the whole lung and systemically. In Aim 1 we will determine the pathway of Mtb dissemination
within the lung using a novel model of ULD-infected mice that mimics better human infection than many other
animal models. In particular, we will discriminate between alternative hypotheses of Mtb spread in the lungs
such the “bubble model” (in which Mtb spreads locally between lung lobes) and the “reseeding model” (in which
Mtb spreads hematogenously to different parts of the lung after disseminating systemically). In Aim 2 we will
determine the contribution of different cell populations, including Mtb-speciﬁc CD4 T cell response, to kinetics of
Mtb dissemination systemically in mice infected with conventional doses (CD, 150 CFU) of Mtb. To parameterize
best ﬁt models we will use data from experiments with Mtb H37Rv carrying the replication clock plasmid pBP10.
Finally, in Aim 3 we will attempt to improve on our recently derived mRNA-based gene signatures predicting
CFU in murine lungs using cutting-edge graph theory-based methods of data dimensionality reduction. We will
also perform experiments and deﬁne a new signature predicting disseminated TB in mice, and test its accuracy
using data from monkeys and humans. Taken together, by combining experimental data from highly innovative
experiments involving novel techniques (ultra low dose infections, barcoded strains, replication clock plasmid,
microarray-based gene signatures) we will provide a quantitative understanding of how Mtb disseminates in the
lung and systemically in the body.

Public health relevance
Research Narrative Tuberculosis (TB) remains a major health problem in the world. While TB is primarily a disease of the lungs, extrapulmonary TB is common in children and immunocompromised individuals. We propose combining mathe- matical modeling and experiments to gain insights into mechanisms of Mtb dissemination using a novel system of infection of mice with an ultra low dose (1-3) of bacteria.